Strengthening of MBRS-SCORE Program at SSU

[unreadable] DESCRIPTION (provided by applicant): Savannah State University (SSU) operated a minority biomedical research support (MBRS) program from 1975-1989; the program provided training for several undergraduate students and faculty in the College of Sciences and Technology (COST). In 1999, Dr. Chetty's (Program Director's) MBRS-SCORE approved project was funded under R21 mechanism for 2 years to establish a Core-Facility and rejuvenate the biomedical research program. In April 2001 SSU established MBRS-SCORE program with one sub project and one pilot project. One pilot project submitted as part of the supplemental grant application submitted in October 2001 was approved and funding was received in August, 2002. One subproject and two pilot projects submitted in this application by COST faculty will further strengthen the biomedical research program at SSU. Recently, COST acquired several items of modern equipment through Federal and State grants, seed money from the NIH/ERDA project to improve the research infrastructure and initiate faculty research and MARC U*STAR program for minority undergraduate students to participate in biomedical research. The MBRS program seeks funding to revitalize and further stimulate the biomedical research at SSU. The primary goal of this project is to involve and motivate the faculty to conduct competitive and advanced research in the biomedical sciences. The Scope of the sub-projects and pilot projects in the application include neurotoxicology, marine ecology and medicinal chemistry. The MBRS program at SSU proposes the following activities: 1) to motivate and enhance faculty development in biomedical research, 2) to strengthen and maintain the modern Core Facility for faculty and undergraduate biomedical research, and 3) to improve the collaboration of SSU with other research intensive institutions. The faculty participating in the MBRS program are highly qualified scientists and have an impressive record of research publications. If funded, the proposed program will enable SSU to strengthen its biomedical research base and enhance opportunities for the faculty to seek competitive funding for research. [unreadable] [unreadable]